Mechanisms for post-COVID pituitary damage

PROJECT SUMMARY
COVID-19–related extra-pulmonary damage is common and may even be observed in patients with mild COVID-
19 symptoms. There is an urgent and immediate need to establish optimal post-infection health care strategies
for these patients, yet mechanisms underlying their appearance remain unexamined. For example, post-COVID-
19 chronic fatigue syndrome has been reported in 54% of COVID-19 survivors, including those without severe
symptoms during the acute infection; however, its cause has not been addressed. Post-COVID-19 chronic
fatigue syndrome’s symptoms mimic those experienced by patients with well-described pituitary hormone
deficiencies, supporting the concept that pituitary dysfunction in patients with COVID-19 may be implicated in
post–COVID-19 health complications. Several lines of evidence support the premise that SARS-CoV-2 infection
damages the pituitary, leading to disrupted pituitary function. First, we detected expression of the SARS-CoV-2
receptor ACE2 in the normal human pituitary by immunofluorescence, suggesting that SARS-CoV-2 may directly
damage pituitary endocrine cells. Second, it has been reported that the SARS pandemic in Southeast Asia in
2002, by SARS-CoV-1, caused post-infection pituitary function decline, although direct damage to the pituitary
was not investigated. Third, clinical observations suggest that patients with COVID-19 show aberrant immune
activity and may develop cytokine storm, with particularly acute elevations of IL-6 and TNFα. Cytokine storm,
which can occur as a consequence of with cancer immunotherapy treatment, for example, is frequently
associated with pituitary inflammation and dysfunction, although the detailed pathogenetic mechanisms are not
known. This suggests that aberrant activation of the immune system may also indirectly damage the pituitary in
patients with COVID-19. Elucidating the mechanisms underlying direct and indirect pituitary damage related to
SARS-CoV-2 infection is critical to establishing guidelines for timely diagnosis and management of pituitary
dysfunction in COVID-19 survivors. In Aim 1, we will determine whether SARS-CoV-2 directly invades the
pituitary and causes pituitary structural damage. We will study autopsy-derived pituitary tissues obtained from
COVID-19 deceased patients and normal control pituitary tissues. Moreover, using a novel spatial genomics
technology, we will determine changes in gene expression associated with COVID-19 in each of the five pituitary
endocrine lineages and stroma cells. In Aim 2, we will determine the association and the timeline of pituitary
dysfunction and symptoms in patients who were infected by SARS-CoV-2. By combining detailed and innovative
cellular and molecular analyses, and clinical studies, we will identify the mechanisms responsible for pituitary
dysfunction in COVID-19 patients and determine the course of pituitary dysfunction in COVID-19. These
innovative studies will, in turn, enable the development of an evidence-based clinical guide for evaluation and
management of hormone deficiencies in the vast COVID-19 population across the globe.

Public health relevance
Project Narrative This proposal will determine the underpinning mechanisms of a major complication of SARS-CoV-2 infection, pituitary dysfunction and its consequent hormone deficiencies, which are associated with increased burden and decreased quality of life in these patients as well as increased societal and health costs, in part due to delayed diagnosis. These studies, which have a very high likelihood of success, will provide a strong foundation for the development of protocols aimed at efficient and accurate identification of patients with, or at increased risk of, pituitary dysfunction, so that these individuals can be identified in a timely fashion and selected for therapies aimed at preventing or minimizing pituitary dysfunction in this population. Moreover, the novel detailed mechanistic studies we propose will also inform research into other COVID-19 complications, and potentially other disease processes associated with pituitary dysfunction.